Full Project 1

Most luminal B breast cancers (LBBC; ER+, HER2-wt, Ki67>14%) carry a good prognosis. However,
approximately 20% of LBBC are highly aggressive and resistant to current therapies. Poor-prognosis LBBC
disproportionally impact women of African descent; the majority are MYC-activated. There have been many
failed attempts to therapeutically target MYC. These attempts have failed, in part, due to our current inability to
separate the cancer-promoting activities of MYC, mechanistically or therapeutically, from its normal essential
cellular functions. In preliminary data, we show that the cancer-transforming ability of MYC is dependent on three
lysine (K) residues of MYC (K149, K158, and K323) that are major substrates for acetylation by the histone
acetyltransferases (HATs) p300 and GCN5; individual substitutions of these specific sites block the ability of
MYC to transform human mammary cells. Guided by our preliminary data, here we aim to dissect the cofactors
and molecular mechanisms by which these MYC acetyl-K (AcK) residues promote cell transformation and
initiation and progression of LBBC. Our long-term goal is to identify new “druggable” targets to improve survival
of women most affected by aggressive LBBC; consequently, our studies will focus on women of African-descent.
Guided by our preliminary data, we hypothesize that a gene-selective MYC-AcK signaling pathway drives the
aggressive tumor cell biology of therapy-resistant LBBC and involves transcription cofactors and epigenetic
coregulators that “write” and/or “read” AcK marks on MYC and histones, perhaps including cofactors co-
overexpressed with MYC in LBBC, such as PIN1, GCN5, p300, and/or YEATS2. Here, we will investigate the
role of MYC-AcK dependent signaling in luminal mammary cell transformation and aggressive progression of
luminal cancer cells and LBBC tumors as well as identify the cofactors and mechanisms involved.
Characterization of this new MYC oncogenic signaling pathway may provide biomarkers and/or therapeutic
targets for LBBC in women of African descent. Aim 1 will test the impact of MYC-AcK dependent signaling in
mammary epithelial cell transformation and in the aggressive biology of LBBC in women of African-descent. Aim
2 will characterize the molecular mechanisms of MYC-AcK dependent gene regulation in transformed mammary
epithelial cells and in LBBC cells and tumors from women of African-descent.